Trajectories and Markers of Neurodegeneration in Fragile X Premutation Carriers

FMR1 premutation carriers exhibit mild cognitive impairment and have an increased rate of
psychiatric disorders.
Critically, they are at risk for developing a neurodegenerative disease, fragile X-associated
tremor/ataxia syndrome (FXTAS), which is characterized by progressive gait ataxia, intention
tremor, Parkinsonism, dementia, autonomic dysfunction, peripheral neuropathy and key
neuropathological features. The disease has a variable and age-related penetrance, affecting 75% of
male premutation carriers by the eighth decade of life. Given the high prevalence of the FMR1
premutation in the population (about 1/468 males) this is a significant health issue that affects a
large number of individuals. There is currently no treatment for FXTAS and no empirically evaluated
interventions to prevent or slow the disease progression. Importantly, no biological or behavioral
markers are available for predicting which premutation carrier will develop FXTAS before the
clinical symptoms appear. In the last funding period of our program of research (“Trajectories and
Markers of Neurodegeneration in Fragile X Premutation Carriers”) we have successfully followed FMR1
premutation carriers and age-matched controls for at least two, and in some cases 3 longitudinal
time points, obtaining neuroimaging, neuropsychological, and molecular measurements as well as
medical and neurological examinations. We have identified neuroimaging, behavioral and molecular
markers that show promise for predicting, before the onset of clinical symptoms, which premutation
carriers will convert to FXTAS, and for tracking changes during the early stages of disease. Ours
remains the only prospective, longitudinal study of FMR1 premutation carriers being conducted, and
understanding the prodrome of FXTAS remains critical for the early intervention and prevention of
this neurodegenerative disease. For the current project, we will continue to collect longitudinal
neuroimaging, neuropsychological and molecular data from our existing cohort and a new cohort of
carriers and controls with an overarching goal to define the prodrome of FXTAS, refining our
protocol in accordance with what we learned in the last five years, and adding biomarkers and
clinically sensitive measures and assessments of lifestyle factors to better address hypotheses
about risk and resilience in this population.

Public health relevance
PROJECT NARRATIVE Carriers of the fragile X premutation are at increased risk for developing a late-onset neurological disease, Fragile X-Associated Tremor Ataxia Syndrome (FXTAS); however, it is not known why, how, and when some individuals become affected and others do not. This study follows a group of men with the premutation and healthy controls in a longitudinal study to examine the trajectory of change in brain structures, neuropsychological and neurological functioning, and genetic markers in an effort to determine factors explaining the early disease process that will occur in some of these men, and to develop sensitive measures for tracking response to intervention in future studies.